Caesarean Delivery's Effect on the Early Life Microbiome and Neurodevelopment

PROJECT SUMMARY / ABSTRACT
The microbiome is the community of bacteria, fungi, and viruses that live in and on a host. Over the past few
decades, advances in sequencing technology have allowed us to better understand the composition of the
mammalian microbiome and the ways it affects host development. Recent evidence shows that Caesarean-
section delivery, though a medical necessity for some births, may disrupt the vertical transfer of microbiota
from mother to child. This can cause different microbial communities during critical periods of development.
The brain may be particularly sensitive to microbiome changes because neurogenesis in many brain regions
and myelination continue through childhood. This may be one explanation for the increased prevalence of
neurodevelopmental disorders like autism spectrum disorder and attention deficit hyperactivity disorder that are
associated with Caesarean delivery. Nevertheless, it remains unknown whether microbial communities, and
specifically those caused by differential birth mode, can cause neuroanatomical changes. To advance our
understanding of Caesarean delivery’s effect on neurodevelopment, we will use a mouse model of Caesarean
delivery that will allow us to separately quantify the effect of birth mode on both the offsprings’ microbial
communities (Aim 1) and neurodevelopment (Aim 2). We hypothesize that perturbation of the infant
microbiome by Caesarean delivery will disrupt the normal pattern of neurodevelopment in pre-weaning mice (≤
postnatal day 21). To test this hypothesis, in Aim 1 we will study microbial communities through next
generation sequencing, community structure analysis, and predicted bacterial gene content . Additionally, the
direct and local effects of the microbial community will be quantified by mRNA transcriptomic analysis of
gastrointestinal tissues. In Aim 2, we will study brain development through histology and transcriptomics of the
cerebellum and hippocampus. Both regions exhibit neurodevelopment in the early postnatal period and are
implicated in the pathogenesis of neurodevelopmental diseases. Gene expression will be quantified in each
brain region through mRNA transcriptomics. The results of this proposed study may inform targeted
microbiome-based interventions that restore microbial composition and function and facilitate proper
neurogenesis. This research will be completed between two labs at Rutgers university that have expertise in
microbiome analysis and neurodevelopment. The fellow will receive training to achieve his goal of becoming an
independent physician-scientist. This will entail field-specific training in microbial ecology and neuroscience, as
well as the generalizable skills necessary to become an independent investigator, including: experimental
design, scientific writing and communication, and presentation skills.

Public health relevance
PROJECT NARRATIVE The microbiome is associated with neurodevelopmental phenotypes in many human diseases, including autism spectrum disorder, attention deficit hyperactivity disorder, and schizophrenia. Though we know that mode of delivery can determine the initial seeding of the microbiome, we do not know how it may affect neurodevelopment. This work will use a mouse model of Caesarean-section delivery to determine how birth mode changes the pre-weaning microbiome and neurodevelopment in specific brain regions.